Students Training in Advanced Research (STAR) Program

PROJECT ABSTRACT
This is a competing renewal application of the highly successful UC Davis T35 STAR (Students Training in
Advanced Research). The program has trained 300 DVM students over the last 25 years. Students are
encouraged and mentored to submit hypothesis-driven research proposals during the first and second years of
their veterinary training program. The objective of the STAR program is to provide DVM students stipend support
to join experienced training faculty members and their productive research teams in 10 weeks of structured
research mentoring and hands-on modern biomedical research. The program emphasizes 5 fundamental
research objectives: 1) how to gain knowledge and understanding of one’s field of science; 2) how to formulate
a scientifically sound and testable hypothesis; 3) identify specific objectives, conduct control methodical
experiments, and develop technical expertise; 4) analyze results, derive conclusions, propose additional
experiments, and anticipate new directions; and 5) convey research findings succinctly and convincingly to
others. Responsible conduct of research and scientific rigor are key components of the training plan. The STAR
program has consistently received 48 applicants annually, with 15 positions supported by the NIH T35
mechanism for students interested in participating in NIH-relevant research. Students with broad interests
ranging from molecular and cellular medicine to biomedical engineering, vector-borne diseases, and
epidemiology will be trained. The program maintains 44 faculty trainers with proven successes in undergraduate,
predoctoral, and postdoctoral training. Thus, students have access to research projects conducted not only on
a variety of lab animal species (C. elegans, zebrafish, rodents, non-human primates) but also clinical research
on companion and food animals and transdisciplinary “One Health” research experiences about disease
emergence and transmission at the interface of animals, humans, and their environment. Our students are from
diverse backgrounds, underrepresented in veterinary medicine, and largely female. As such we have shifted
our trainers to serve as appropriate role models with an increasing number of veterinary clinician scientists and
women. The greatest strengths of our short-term training program include the outstanding quality and motivation
of our DVM students, the strong, highly collaborative, multidisciplinary nature of our research programs, and
student access to translational research projects that use innovative approaches. Trainees will have access to
advanced technologies, such as epi/genomics and metabolomics, proteomics, state-of-the-art imaging, BSL3
labs, genetically modified organisms, and gnotobiotic and inhalation facilities. Over 50% of the trainees from our
program have pursued additional research training after STAR in the last 15 years. This five-year competitive
renewal application requests to maintain support for 15 DVM students per year for each of five years (a total of
75 students) in order to maintain T35 program missions and spark the interest of the next generation of DVM
clinician-scientists that will take leadership positions in academia, government, and the private sector.

Public health relevance
PROJECT NARRATIVE The UC Davis T35 Students Training in Advanced Research (STAR) program provides DVM students with a balanced experience in hands-on hypothesis-driven research that builds broadly applicable skills in critical thinking and problem-solving. The proposed training program is consistent with recommendations to give federal agencies more control over the number of trainees, the quality of their training, and the appropriateness of training to meet pressing societal needs. Funds are requested to supplement 10-week stipend support for 15 DVM trainees annually, who will receive a combination of didactic and experiential training in rigorous research methodology and science communication at the interface of animals, humans, and their environment.